METABOLIC CONTROL OF TISSUE SPECIFIC MACROPHAGE DIFFERENTIATION

DESCRIPTION (provided by applicant): Macrophages have important immune as well as local tissue homeostatic roles, and altered macrophage function is suspected to contribute towards many disease processes including atherosclerosis, metabolic syndrome, and cancer. Macrophages exist in several specialized forms (subsets) that have distinct anatomic locations, cell surface markers, and functions. While circulating monocytes are thought to give rise to these tissue-specific macrophage subsets, the developmental basis for such tissue-specific differentiation is unknown. Previous published work from Dr. Kenneth Murphy's laboratory demonstrated for the first time the requirement for a specific transcription factor (SpiC) for the development of a specific macrophage subset (splenic Red Pulp Macrophage, RPM). The primary homeostatic function of RPMs is to degrade heme and recycle the iron for subsequent erythropoesis. The candidate's work in Dr. Murphy's lab has focused on understanding the regulation and function of SpiC in RPMs. Surprisingly, this work has discovered that SpiC expression is induced by a metabolite of erythrocyte degradation, heme. Further studies uncovered a role for the transcriptional repressor Bach1 in heme mediated regulation of SpiC. These findings demonstrate a role of tissue-specific metabolites in directing macrophage diversity. The goals of this project are to characterize the mechanisms underlying heme-mediated induction of SpiC, uncover the developmental program controlled by SpiC in RPM biology, and investigate the physiological and pathological implications of heme-mediated induction of SpiC. The work proposed here will be carried out in the laboratory of Dr. Kenneth Murphy, who has recently made significant contributions to the area of macrophage and dendritic cell development and function. The candidate is a MD/PhD who has completed residency training in Clinical Pathology and wishes to train further in basic sciences. The long term goal of the candidate is to establish an independent research laboratory investigating the role of macrophages in disease processes.

Public health relevance
PUBLIC HEALTH RELEVANCE: Macrophages play a critical role in the innate immune system as well as local tissue homeostasis. Different tissues harbor distinct macrophage subsets. Circulating monocytes are thought to differentiate into tissue specific macrophages, but the developmental mechanisms controlling this tissue specific differentiation are not known. The proposed research explores the novel hypothesis that tissue specific metabolites induce na�ve monocytes to differentiate into tissue specific macrophages. This pathway may also have important implications in pathologic states as described in this proposal.